Admin Core

The Administrative Core will be directed by Dr. McKee and the Administrative offices will be located at the
Boston University Alzheimer's Disease Center (BUADC) and CTE Center at Boston University School of
Medicine. The leadership, administrative management and coordination of the proposed activities will be based
on the prior experience and success of 2 previous harmonized UO1s (McKee, PI, Dams-O'Connor, PI). This
U54 application includes 3 well-integrated projects, 3 cores and utilizes 8 brain banks across BUSM and
ISMMS. Each project and core complements the others so that a synergistic relationship is achieved with a
common focus on the major goals of the program: to comprehensively characterize the neuropathological
substrate of neurodegeneration after TBI and RHI, to describe the associations between neuropathological
burden and ante mortem clinical symptoms, to elucidate the contribution of key individual (gender, age at time
of injury, time since injury, genotype, cardiovascular health and cognitive reserve) and injury characteristics
(severity, frequency) to describe associations between neuropathological burden and clinical symptoms and to
determine the prevalence of TBI-related parkinsonism, dementia and CTE in 8 participating brain banks. This
U54 will develop the largest brain donor cohort with well-characterized histories of RHI and TBI across the
severity spectrum and the tissue collected will be used for broad sharing through the UNITE (VA-BU-CLF)
brain bank and the NIH biobank at ISMMS. The U54 will also develop a digital library of pathology slides that
will be hosted and shared by FITBIR. The administrative core will provide overall leadership and organization
to ensure regular, coordinated scientific interaction, harmonized data acquisition, and harmonized clinical and
neuropathological assessment across sites. The administrative core will also manage all communication,
reporting, dispute resolution, use of resources and meeting milestones. To accomplish these goals, the
following components will be assembled: a Scientific Advisory Board (SAB) consisting of 5 leading
independent scientific experts in neurology, neuropathology, TBI, RHI, AD, ADRD, and CTE; an Executive
Committee (EC), the central decision-making and policy development group for the proposal; a Scientific
Working Group (SWG) to ensure scientific advancement and productivity through sharing of scientific results
and discussion; a Publications Committee; a Tissue Request Oversight committee and a Fiscal Management
Committee. The Administrative Core will ensure that all U54 milestones and metrics for each project and core
are met. Given the well-established, productive working relationships between the PI, project and core leaders
and investigators at BUSM and ISMSS and their proven track record of success, we are confident that the
Administrative Core can effectively support the 3 inter-linking cores and projects to fully achieve the proposed
goals and milestones of this U54.